Metal catalysis in transformations of organic compounds

PROJECT SUMMARY
Organic molecules play an important role in research areas relevant to human health, including
biology, medicine, and drug development. One of the main goals of synthetic organic chemistry
is to facilitate discovery in these fields by providing access to organic molecules of increasing
complexity and variety, and by expanding our ability to efficiently manipulate their structure and
other properties. As a result, the development of new organic transformations is a critically
important goal of organic chemistry with implications to other research areas relevant to human
health. We plan to develop new catalytic transformations for alkene synthesis by exploring the
reactivity of organoboron compounds in the presence of transition-metal catalysts. The proposed
transformations will also directly address enduring challenges in organic synthesis, such as cross-
nucleophile coupling, stereocontrol in synthesis of highly substituted alkenes, two-carbon
homologation, and C-C bond activation. Once successfully developed, these transformations will
greatly facilitate access to complex alkenes from a wide range of common precursors.
Considering the importance of alkenes as reactive intermediate in organic chemistry, this will have
significant impact on the synthesis of biologically relevant compounds.

Public health relevance
Project Narrative: The progress of modern medicine has been directly related to the increased ability of scientists to prepare and manipulate complex organic molecules used as pharmaceuticals and research tools in biology and medicine. We are developing new tools for organic synthesis that will contribute to our ability to access organic molecules of increasing complexity and variety, and facilitate their use in areas of research directly related to human health.